A control center for mitochondrial navigation in neurons

Project Summary from Parent Grant 1R01GM143258
We seek to understand the regulatory mechanisms that control the movements of mitochondria
in cells. A protein complex that includes milton, Miro, and the kinesin-1 heavy chain (KHC) is
essential for mitochondrial transport in neurons. Miro resides at the central hub to allow multiple
cellular signals to control mitochondrial motility. These signals include mitophagy, calcium,
hypoxia, and nutrient availability etc. Additionally, and most relevant to this proposal, we have
obtained exciting preliminary results demonstrating that a novel machinery spanning both the
mitochondrial outer and inner membranes–the mitochondrial intermembrane space bridging
(MIB) complex, stabilizes Miro and regulates mitochondrial motility. This new discovery and our
past work raise a burning question at the intersection of fundamental cell biology and
neurobiology: How these discrete Miro-pathways functionally coordinate or converge on
mitochondrial integrity in response to various stimuli and stresses? In this proposal, we will
probe these questions using classical cell biological and neurobiological approaches combined
with a powerful genetic tool (fruit flies) for functional validation. Aim 1: To dissect the functional
significance of the MIB-Miro complex. Aim 2: To determine the nature of Miro interaction with its
binding partners. Aim 3: To explore the interplay of the regulatory signals and machineries of
Miro.

Public health relevance
Project Narrative from Parent Grant 1R01GM143258 Mitochondrial transport and mitophagy are crucial to neuornal survival and have been implicated many neurodegenerative diseases such as Parkinson's disease, Alzheimer’ disease, and Amyotrophic lateral sclerosis. These diseases afflict millions of people worldwide with tremendous global economic and societal burdens. This proposal will elucidate the mechanisms underlying neurodegeneration, and is therefore relevant to public health and the mission of the NIH, as it will provide novel targets for therapeutic intervention.